An Electronic Health Record based Dashboard-driven Intervention to Improve Identification and Management of Preventive Care for Cardiovascular Disease

Cardiovascular disease (CVD) is the leading cause of mortality both in the United States and in the world, and is one of the most costly chronic conditions. The incidence of CVD triples at age 40-50 compared to younger age, and increases 50% or more at each decade of age after that, is also strongly associated to race and ethnicity. Though CVD related preventive cares have been recommended by USPSTF guideline, only less than 40% at risk patients complete one of those preventive cares timely. The objective of the project is to develop, implement, and evaluate an electronic health record (EHR)-based preventive care dashboard management tool and team-based intervention to improve compliance of CVD related preventive care for primary care patients 50 years and older. The proposed dashboard is seamlessly integrated within the electronic health record (EHR) to: (a) identify adults with CVD risk; (b) suggest personalized CVD related preventive components and associated recommendations of action (e.g. screening test order, medication order, etc.) at point-of-care visit with primary care providers; and (c) engage population health management teams between visits. The development and pilot test will take place during R61 phase. In the R33 phase, we rigorously test the impact of the tool using a cluster randomized controlled trial with ~200 primary care physicians and assess intervention impact on completion of 4 key preventive care elements for patients at risk for CVD: (1) diabetes screening, (2) blood pressure monitoring; (3) lifestyle (smoking cessation, diet and physical activities); (4) appropriate aspirin and statin use. The intervention, referred to as CVD Preventive Care Dashboard Management (CVD-PCDM) tool, provides patient-specific and clinician-specific CVD preventive care recommendations and risk estimate in low-literacy format to the primary care provider (PCP) and patients at each primary care encounter to facilitate shared decision making and patient education. This CVD-PCDM will be co-designed with clinicians using a successful digital solution development and test cycle which has been tested in other similar dashboard systems current running at Sutter, and implemented in primary care clinics. Scalability of the CVD-PCDM will be first tested within Sutter in two geographically and racially distinct operation units. Meanwhile, we will also identify one health care system from Health Care System Research Network (HCSRN) to duplicate the intervention and assess the effect. HCSRN consists of large health care systems in the US, and has actively promoted collaborative research. If the CVD-PCDM is effective at Sutter, the codes and development package will be shared with the second site. We will design a digital solution scalable pipeline that can be rapidly and consistently translates this guideline-based preventive care into delivery of personalized and coordinated CVD care within primary care settings.

Public health relevance
Preventing and managing the key Cardiovascular (CVD) risk factors including unhealthy lifestyle, diabetes, hypertension, hyperlipidemia, and smoking is one of the most effective ways to diminish the burden of CVD. This project focuses on development an Electronic Health Record-based CVD preventive dashboard management tool (R61 phase) to improve compliance with USPSTF guideline-based preventive care for CVD, and rigorously assess the impact of tool in a cluster randomized trial for people at elevated risk, including older age groups (≥50 years) and people from racial and ethnic minorities (R33 phase). This low-cost and highly scalable tool has high potential to improve CVD preventive care and translates personalized preventive care through re-engineering EHR into tangible health benefits for large numbers of patients with CVD risk.